Tumor-targeted pH-sensitive manganese oxide nanoparticle for enhanced breast cancer detection using MRI

Approximately 2.1 million women globally will be diagnosed with breast cancer each year and over
626,000 women will die because of it. Triple negative breast cancer (TNBC) is the most aggressive subtype,
with the greatest potential to metastasize and recur despite treatment. Our long-term goal is to develop an
innovative contrast agent for enhanced early detection of TNBC recurrence that will greatly reduce the false
negatives and false positives associated with current breast imaging techniques.
Magnetic resonance imaging (MRI) detects more breast cancers than mammography; however, false
positive diagnoses remain high with MRI due to the standard contrast agent used (e.g. gadolinium chelate).
Gadolinium chelates are non-targeted MRI contrast agents that always generate signal, which leads to the
inability to accurately distinguish benign from malignant tumors. Our approach is drastically different. Herein,
we will develop novel tumor-targeted pH-activatable manganese oxide (MnO) nanoparticles (NPs) for early
and specific breast cancer MRI detection. MnO NPs present a targeting peptide that binds to
underglycosylated mucin-1 (uMUC-1) overexpressed on breast cancer cells. MnO NPs will be endocytosed
specifically by cancer cells and dissolved in low pH endosomes to release Mn2+ ions to initiate MRI signal.
Unlike conventional MRI, our targeted MnO NPs will specifically detect malignant tumors but not benign
tumors, as uMUC-1 is only present on breast cancer cells. By reducing false positives, our approach will
avoid unnecessary biopsies, surgery, further imaging, anxiety, and save up to $3 billion in medical bills
annually. In addition, MnO NPs can promote detection of smaller tumors, as Mn2+ has higher relaxivity than
gadolinium chelates and NPs can deliver more Mn2+ to the cancer site. Due to earlier diagnosis and prompt
treatment enabled with our detection strategy, patient survival will be significantly increased.
We hypothesize that uMUC-1 targeted pH-activatable MnO NPs will specifically label malignant breast
tumors expressing uMUC-1 in vivo and produce sufficient MRI contrast to visualize smaller tumors than
conventional gadolinium chelates. We will test this hypothesis with the following aims: 1) Design targeted
pH-activatable MnO NPs to preferentially accumulate within TNBC tumors expressing uMUC-1 in vivo. 2)
Determine degree of toxicity and biodistribution of targeted MnO NPs. 3) Establish potential of targeted pHactivatable
MnO NPs for detecting smaller TNBC tumors compared to Multi Hance.